A fast CTOT for mapping whole brain hemodynamic activity in infants

Abstract
Although Blood Oxygenation Level Dependent (BOLD) functional MRI (fMRI) is widely used to examine brain
activation in adults, technical and logistical challenges frequently limit the ability to perform fMRI scans readily
and longitudinally in infants, particularly in those at greatest risk for adverse neurodevelopmental outcomes and
developmental delays. As a consequence, prognostics are made on general basis and cannot be individualized
for optimal management. Functional Near-Infrared Spectroscopy – Diffuse Optical Tomography (fNIRS-DOT)
imaging promises to be an alternative imaging technique. The current fNIRS-DOT imaging are limited to cortex
regions and unable to interrogate deep structures such as the basal ganglia and thalamus that are often involved
premature infant brain injury. Recently, we reported a continuous wave-based transcranial near infrared optical
imaging system, called Cap-based Transcranial Optical Tomography (CTOT) that employed a single, GaAs
intensified, CCD detector array to image whole brain hemodynamic activity in an awake child with seconds of
acquisition time. However, the substantial readout time of the CCD detector and slow mechanical switching of
source and detector fiber optics resulted in large dead-times that lengthened measurement times. Armed with
our preliminary data of the clinical feasibility, we propose to speed up measurement times by adapting recent
advances of fast read-out, scientific CMOS detector arrays along with microelectromechanical systems (MEMS)
for novel dynamic range control, automated calibration, and optical switching of source and collection fiber optics
in order to enable sub-second, dynamic CTOT mapping. The significance and innovation of this approach will
be substantial, as never before has a nonintrusive, noninvasive methodology been developed to completely
elucidate whole brain hemodynamic activity in infants. Our specific aims are to: (1) refine our CTOT imaging
system with a single, GaAs intensified integrating detector, a MEMS optical switch for source fiber optics and a
digital micromirror device for detector fiber optics to enable rapid, dynamic imaging; and (2) validate CTOTfNIRS
derived hemodynamic activity in infants undergoing BOLD fMRI. If successful, the proposed work will provide
the first, rapid whole brain CTOT imaging system for sensitive assessment of brain hemodynamic activity in
infants. In the short term, CTOT images will eventually help parents, physicians and therapists best plan and
care for children with brain deficits so that their quality of life is optimized as they progress through childhood.

Public health relevance
Current functional near-infrared spectroscopy systems have some technical restrictions that limit the extent of whole brain functional imaging. In this application, we propose to develop a whole brain, functional near- infrared spectroscopy system that is sensitive and rapid enough for assessing brain hemodynamic activity in infants. This imaging technique will allow economical, bedside diagnostics for prognostication and, hopefully in the future, strategic therapeutic interventions that can positively alter outcomes.